High throughput isotropic resolution fluorescence and second Harmonic imaging to characterize tendon injury

The objective of this application is to develop advanced multiview (MV) deconvolution tomography of cleared
tissue using high resolution two photon microscopy (TPM) and utilize it to shed new mechanistic insights about
the myofibroblast microenvironment in fibrovascular peritendinous adhesions. Advances to our understanding of
the cellular and molecular events involved in tendon adhesion using transgenic mouse models, which could lead
to disease modifying therapies, are often hindered by reliance on 2D histology sections and single-cell analysis
techniques, neither of which can put cellular interactions or molecular processes into their 3D spatial context.
Alternatively, microscopy techniques such as TPM and light sheet microscopy (LSM) can provide spatial context,
but struggle to simultaneously provide the throughput, contrast and resolution required to map the cellular
processes involved in tissue healing over physiologically relevant spatial and resolution scales and so are not
widely used in tendon biology. To overcome these limitations, we have developed protocols for immunolabeling
and tissue clearing of tendon injury models and demonstrated molecular and second harmonic generation
(SHG) imaging of tendon in situ. Our proposed advances in detection electronics and imaging enable two
photon microscopy two orders of magnitude faster than conventional microscopes and multicolor imaging
at rates comparable to or exceeding LSM. Finally, we propose a novel approach to MV deconvolution, which
simultaneously acquires multiple angular views to decrease focal volumes by an order of magnitude, enabling
isotropic resolution tomographic imaging of tissues. We combine these technical advances into a high
throughput platform for 3D spatial immunophenotyping and proteomics and then apply it to understanding the
complex mosaic of vascular and inflammatory cells, extracellular matrix (ECM), and signaling (TGF-
β1/mTOR) in the myofibroblast microenvironment, to shed new mechanistic insights that could lead to discovery
of cellular and molecular targets for biologic therapies. The aims for this proposal are: Aim 1 will develop a new
approach to tomography using MVD based on simultaneously imaging two angular views that will accelerate
imaging and reduce the extreme computational complexity required to fuse two sequentially acquired volumes
together. Eight channel acquisition will enable dense spectral multiplexing of probes and a deconvolution,
enabling efficient quantification of spatial relationships between reporters at sub-wavelength scale. Aim 2 will
apply MV-TPM to tomographically profile the myofibroblast microenvironment to build spatial cellular interaction
networks of innate and adaptive immune cells within the vascular inflammatory microenvironment of
myofibroblasts. Aim 3 will utilize MV-TPM imaging to map TGF-β1/mTOR signaling in the myofibroblast
microenvironment and subsequently inhibit it to validate its role in adhesions. When completed, the proposed
work will develop a high throughput 3D spatial immunophenotyping and proteomics imaging platform to shed
novel mechanistic insights and discover new biologic therapies.

Public health relevance
Project Narrative This proposal will combine tissue clearing, two photon microscopy, and multiview imaging to develop new and quantitative tools for investigating animal models of musculoskeletal injuries. These tools will then be applied to 3D spatially map inflammatory cellular and molecular signaling in tendon injury models, leading to a better understanding of the pathology, which could lead to new therapies.